DEXRAZOXANE, DOXORUBICIN AND PACLITAXEL PLUS GCSF IN ADVANCED BREAST CANCER

Metastatic breast cancer is almost always incurable with standard chemotherapy, utilized either as single agents or in combination. Combination chemotherapy consisting of cyclophosphamide, doxorubicin (Adriamycin), and 5-Fluorouracil (CAF), or cyclophosphamide, methothrexate and 5-fluorouracil (CMF) are the most commonly employed regimens for the treatment of metastatic breast cancer, resulting in an overall objective response rate as high as 50-70%, complete response rate of approximately 10%, and a median survival of approx. 18-24 mos.